Clemson Light Imaging Facility (CLIF)

PROJECT SUMMARY/ABSTRACT
The Clemson Light Imaging Facility (CLIF) will serve as the Imaging and Cell Sorting Core for
the EPIC COBRE. The CLIF is a multi-user core facility located in the Clemson University Life
Sciences Facility. The core is under the direction of Dr. Terri Bruce, and houses a suite of Nikon
microscopes as well as several high-end Leica microscopes with confocal, multiphoton spectral
confocal, STED Super-Resolution, and HyVolution® capabilities. The core also has a high
content screener (GE InCell Analyzer 2500 HS) and cell sorting equipment (BioRad S3e). The
specific aims of the Imaging and Cell Sorting Core are 1) to promote and facilitate the research
undertaken by the project leaders of this COBRE; 2) to enhance the technical assistance
capacity/capabilities of the CLIF; and 3) to promote and facilitate research at Clemson
University and in the state of South Carolina. Aim 1 will be addressed by providing assistance to
project leaders with design and implementation of visualization and cell sorting experiments,
providing advanced technique and equipment training, and providing organized workshops on
microscopy and advanced cell sorting. Aim 2 will be addressed by the addition of a second full-
time technician, who will assist with experiment development, advanced imaging and cytometry.
Aim 3 will be addressed by hosting educational workshops on advanced light imaging
techniques, the principles and uses of flow cytometry and sorting, and data analysis.